Prospection in suicidal teens: Identifying a novel and malleable cognitive risk factor

PROJECT SUMMARY
Suicidal ideation is an immensely distressing experience that often emerges in adolescence, recurs over time,
and is difficult to treat. It is also one of the most potent risk factors for subsequent suicide attempt and death.
Reducing suicidal ideation among adolescents may not only preempt the transition to suicidal behaviors but
also alleviate distress during a time of critical growth. There are several barriers to advancing research and
clinical care in this area. First, there have been limited studies of the prediction of near-term suicidal ideation.
Second, previously studied psychological precipitants of suicidal ideation pertain to a desire for death when in
fact suicidal ideation involves a deliberation between death and continued life. Third, most psychological
precipitants have been captured using single time-point assessments that have limited ecological validity. In
response to these barriers, a long-term goal of this line of research is to produce real-world strategies to
mitigate suicidal thinking among adolescents. The immediate goal of this proposed R15 renewal is to examine
in suicidal adolescents a candidate psychological precipitant of suicidal ideation: prospection specificity, or the
degree of detail and spatiotemporal localization with which adolescents imagine future events. The central
hypothesis is that poor prospection specificity will predict near-term increases in suicidal ideation. We will test
how adolescents’ prospection specificity is associated with subsequent suicidal ideation and whether negative
affect exacerbates this association. Using ecological momentary assessment (EMA), the proposed renewal will
uncover the everyday experiences of future thinking among recently suicidal and nonsuicidal adolescents (n =
160) across 14 days. Specific Aims are to: (1) compare real-time experiences of prospection between recently
suicidal and nonsuicidal adolescents; (2) test whether real-time prospection specificity predicts subsequent,
near-term changes in suicidal ideation; and (3) test whether the interaction between negative affect and
prospection specificity predicts near-term changes in suicidal ideation. This proposal is innovative because it:
(a) features the rare prediction of near-term suicidal ideation (i.e., within minutes or hours); (b) targets a
historically neglected component of life-and-death deliberations; (c) uses the most ecologically valid depiction
of prospection specificity ever administered to suicidal adolescents; (d) posits the clinical significance of
prospection specificity at an earlier point in life than previously assumed; and (e) integrates the study of
prospection specificity with affective functioning. Findings from this project will improve our understanding of
how prospection operates in real-time among suicidal adolescents, introduce a potential psychological
precipitant of suicidal ideation, and broaden our understanding of affective contexts in which these near-term
predictions occur. These significant knowledge gains will inform whether, when, and in which contexts we can
intervene on this proximal precipitant of suicidal ideation outside of standard treatment settings.

Public health relevance
PROJECT NARRATIVE This proposed R15 renewal examines adolescents’ daily experiences of prospection (i.e., future-oriented cognition) and suicidal ideation, with the goal to uncover whether, when, and in which contexts poor prospection specificity predicts near-term changes in suicidal ideation. Findings will help achieve a more ecologically valid understanding of this candidate cognitive precipitant during adolescence and inform the design of intervention strategies to mitigate suicidal thoughts outside of standard treatment settings. This is relevant to public health because real-time interventions could increase accessibility to strategies for reducing suicidal ideation early in life.